Investigating the Contribution of the Coxiella Cell Wall to Intracellular Pathogenesis

Project Summary
Coxiella burnetii is the highly infectious causative agent of Q fever, which can manifest as an acute or debil-
itating chronic disease. This naturally obligate intracellular bacterium infects alveolar macrophages, replicating
within a compartment that resembles a mature phagolysosome. A distinguishing characteristic of C. burnetii is
its ability to enter these cells without activating detectable innate immune defenses or polarizing the cell to a
proinflammatory phenotype. The virulence factors credited with this pathogenic paradigm are its unique anti-
inflammatory lipopolysaccharide (LPS), and the effectors secreted by its Type IVb Secretion system (T4SS). To
identify unappreciated virulence factors unrelated to LPS or T4SS of C. burnetii, a genetic screen employing
TnSeq compared the replication of Coxiella transposon mutants in Vero cells to that in primary macrophages.
The screen identified a series of mutants in genes related to cell wall function were required for replication only
in the context of the primary macrophages. These data suggested that bacterial cell wall components may belong
to an unappreciated class of Coxiella virulence factors. The long-term goal of this project is to describe the
molecular mechanism(s) by which the identified cell wall components contribute to the intracellular pathogenesis
of Coxiella. The central hypothesis is that the C. burnetii cell wall is specifically adapted to resist or evade the
innate defenses that are present in its preferred cellular host, macrophages. The objectives of this application
are to determine the 1) molecular functions and 2) virulence contributions of individual cell wall components that
are required for Coxiella’s survival and proliferation within primary macrophages. The role(s) of cell wall compo-
nents in Coxiella pathogenesis will be defined by pursuing the following specific aims: 1) determine the func-
tions of the candidate cell wall-related virulence genes, and 2) determine the effect of these cell wall
mutants on C. burnetii-host interactions. Specific aim 1 will focus on the molecular contribution of these
candidate virulence genes to survival and resistance to stresses specifically encountered within macrophages.
We will use multiple experimental approaches including complementation assays, biochemical analyses of pep-
tidoglycan and lipids, developmental and morphological analyses, and in vitro functional assays to define the
contribution of these cell wall components to Coxiella survival. Specific aim 2 will investigate the response of
macrophages to infection with these interesting cell wall mutants. By employing RNAseq, enzymatic activity
assays, and secretion assays, we will build a holistic view of the host response to these mutants. We anticipate
that the proposed series of experiments will lay the foundation for a strong, long-lived research program that
links cell wall integrity to Coxiella burnetii’s distinguishing environmental stability and incomparable ability to
survive in a microbicidal niche.

Public health relevance
Project Narrative Coxiella burnetii, the intracellular bacterial pathogen the causes Q fever, has few described virulence factors outside of its Type IVb Secretion System and lipopolysaccharide. Using a unique cellular model of Coxiella infection, we discovered that multiple genes related to the bacterial cell wall are specifically required for replication in primary macrophages. These genes represent a novel class of cell type-specific virulence determinants for C. burnetii.